Maternal Genetic Effects Shape Developmental Evolution

PROJECT SUMMARY
Variation in the maternal genome alters the way offspring are provisioned and changes many aspects of their
development. These changes in development have cascading effects on the offspring phenotype, life-history,
and fitness. Maternal effects have long been recognized as a major factor in development, and the naturally
occurring variation across maternal backgrounds has profound potential to alter developmental fates. However,
the specific mechanisms and genetic loci involved remain poorly understood. Recently, maternal genetic
effects have been recognized as a major contributor to human health and development through maternal-by-
zygotic epistatic interactions. Here I use Streblospio benedicti, an emerging model, to understand how
maternal genetic effects influence the evolution of developmental programs. S. benedicti produces two
distinct offspring types that differ in egg size, embryogenesis, and larval development. Thus, S. benedicti is an
intraspecific model for the evolutionarily common transition between indirect and direct development, and it
remains the only known organism to have two heritable offspring types. Using S. benedicti I have shown that a
transition from indirect to direct development requires the independent evolution and coordination of both
maternal and zygotic genomes. Recent advances in transgenics and sequencing technologies have made
research on emerging models feasible, and I developed molecular and genomic tools in S. benedicti to answer
these crucial questions; I have constructed the genetic map, a fully assembled and annotated genome,
transcriptome databases, and methods for making transgenics. The research in this proposal will be the
first to investigate the intraspecific genetic basis for evolutionary developmental transitions and will
answer long-standing questions of the role of the maternal genome in shaping developmental
program. Here I use comparative transcriptomics across the developmental types at the oocyte, embryo, and
single-blastomere level, allowing quantification of heterochronic, heterotopic, and heterometric gene
expression across different development types. This approach reveals 1) the genomic-level regulatory
architecture that alters development, 2) the role of maternal factors in initiating developmental and life-history
transitions, and 3) the specific genes involved in these changes. By integrating transcriptomics with population
genomic data, I will produce a complementary set of candidate genes involved in evolutionary-developmental
transitions, which I will validate in future studies. This proposal leverages the genetically tractable
developmental dimorphism in S. benedicti to answer fundamental evolutionary questions at multiple scales,
from the molecular to population level. The resulting genetic architecture and loci found within S. benedicti are
comparable across divergent organisms. This project will reveal the architecture and genetic mechanisms
through which maternal genetic effects shape developmental evolution and lead to novel
developmental programs.

Public health relevance
PROJECT NARRATIVE Maternal genes have important effects on offspring development, but few studies to date have identified how variation in these maternal genetic loci alter regulatory processes and shape developmental outcomes. This project uses a unique model system to understand how genetic interactions between maternal background and offspring genotype influence embryogenesis and ontogeny. Maternal genetic effects impact development in humans through gene-by-gene and gene-by-environment epistasis, and this project contributes to our understanding of how these processes affect human health and development.